Can hydroxychloroquine prevent preeclampsia and preterm delivery in lupus pregnancy?

This is a new application for an R01 award for epidemiologist Dr. Julia Simard, at Stanford
University School of Medicine, who brings an innovative lens to the field as an early stage
investigator building a research program focused on adverse pregnancy outcomes in patients
with systemic lupus erythematosus. For her K01 award, Dr. Simard and colleagues showed that
pregnant women with lupus are a highly-medicated group, who experience more adverse
outcomes, including early-onset preeclampsia, preterm delivery, infection, and stroke. In recent
pilot work, Dr. Simard found that hydroxychloroquine (HCQ), which is used to manage lupus
during pregnancy, may prevent preeclampsia and preterm delivery. In two populations (one US
and one in Sweden), Dr. Simard also found that fewer than half of pregnant women with lupus
use HCQ, despite recommendations. This has been corroborated by others as well.
Dr. Simard builds upon this work in the present application via three large international
populations to determine whether HCQ reduces the risk of these adverse outcomes in lupus
pregnancies. Dr. Simard will partner with colleagues in Sweden, Israel, and Kaiser Permanente
of Northern California’s Division of Research in the United States. These data include details on
ordered and filled prescriptions, and often unavailable data on antiphospholipid antibody status
and parity, two critical factors in lupus reproductive research. In aim 1, Dr. Simard will determine
whether preeclampsia risk is reduced in women who use HCQ during pregnancy. In aim 2, Dr.
Simard will examine preterm delivery, partitioning spontaneous from medically-indicated, to
examine overall risks and medication by preeclampsia and other factors such as glucocorticoid
use and gestational diabetes.
In aim 3, Dr. Simard’s team will identify barriers and facilitators of HCQ use in pregnant women
with lupus using an innovative mixed methods design. After evaluating patient adherence and
guideline adherence by clinicians in the large US and Israeli databases, they will identify
subsets less likely to adhere and examine how they differ from adherent patients. Then
partnering with patients and providers, they will use these quantitative findings to identify
barriers and facilitators of adherence from the patient and provider perspectives using focus
groups. This aim will provide key information on HCQ use and prescription practices to improve
the analytic paradigm and inform our clinical understanding HCQ use in lupus pregnancy, and
provide foundational support for clinical care and possibly, a future clinical trial.

Public health relevance
Systemic lupus erythematosus has been linked to excess preeclampsia in pregnancy and preterm delivery, however promising preliminary data suggest that hydroxychloroquine may protect pregnant women with lupus from these potentially catastrophic outcomes. This work leverages three large population-based databases from around the world (United States, Israel, and Sweden) with detailed prescription and clinical data to address threats to internal validity common in pharmacoepidemiological studies such as confounding by indication and selection bias while disentangling these outcomes from the effects of potential mediators such as glucocorticoids and gestational diabetes. Finally, given that hydroxychloroquine is safe and effective in pregnant women with lupus for managing their disease, we will work with patients and providers to understand why pregnant women with lupus are either choosing not to use this medication or are not being prescribed it in the first place.